Statistics Core

(3) The Statistics Core, led by Drs. Conti, Stram, Azen, and Thomas, will characterize haplotypes, perform association analyses, and comprehensively evaluate the impact of numerous genetic polymorphisms and pharmacological interventions via a biologically motivated Bayesian hierarchical model.